Enriching the All of Us scientific experience for new and existing participants and researchers across the nation

We look forward to building on the foundation we have created through our long-standing partnership with the NIH All of Us Research Program and its consortium partners. Our goals are to further develop and enrich the All of Us scientific experience for new and existing participants and researchers across the nation. We will advance initiatives that focus on holistic knowledge mobilization and research experience strategies to move program priorities forward, ensuring that we deliver the right experience to the right people at the right time.
Participants
We will continue to partner with the NIH and members of the consortium to build, nurture, and sustain partnerships with individuals and families through improved participant digital experience (Goal 1), a focus on short and long-term return of value to the participants (Goal 5), and content and outreach strategies that will support the program’s retention and enrollment efforts (Goal 1 and 5). Some of our key participant-focused priorities will be to support the pediatric and family enrollment expansion, digital enrollment and retention pathway refresh, and the recontact and reassessment campaigns. Furthermore, we plan to continue providing support for Partnered Research Study project rollouts, ensuring the program meets its goal of delivering one of the largest and richest biomedical datasets (Goal 3).
Researchers
To continue ensuring faster, cheaper, and reproducible science, cutting research time from years to hours, we will support timely program initiatives through researcher content and outreach development, thereby empowering researchers, driving innovation, and making precision medicine a reality for people today, leading to better health outcomes for all of us.